Role of Hypoxia-inducible factor-2α signaling in age-induced bone loss

PROJECT SUMMARY
Osteoporotic fractures due to age-associated bone loss impart tremendous economic burden and impair
quality and longevity of life. There remains an undeniable need to identify mechanisms that underlie bone
deterioration with age, for the targeted development of novel therapies that can reverse bone loss to improve
bone quality, fracture resistance, and quality of life. Changes in bone mass during aging occur via dysregulated
skeletal remodeling. Under healthy conditions, skeletal remodeling maintains healthy bone mass and
biomechanical integrity. Homeostatic remodeling balances osteoclastic (OC) bone resorption and osteoblastic
(OB) bone formation coordinated by osteocytes (OCYs). OCYs are terminally differentiated OBs embedded
within the bony matrix that live for decades and are the most abundant cell type in bone. OCY hypoxia
inducible factor (HIF) signaling is an obligate regulatory pathway in skeletal health and maintenance. HIFs are
transcription factors composed of an oxygen-dependent α subunit (transcriptionally active isoforms: HIF-1α,
HIF-2α) and constitutively stable ß subunit (HIF- ß). HIF-α isoforms stabilize under hypoxia and induce skeletal
changes. Skeletal Hif2a expression increases with age, concomitant with senile osteoporosis, and
heterozygous Hif2a depletion abrogates senile osteoporotic bone loss. Cellular senescence associates with
age-induced osteoporotic bone loss. Senescence is characterized by irreversible growth arrest and secretion
of pro-inflammatory and matrix-degrading factors, creating a toxic microenvironment that drives age-related
tissue dysfunction. Hif2a levels increase with age, concomitant with expression of canonical senescence
markers p16 (Cdkn2a) and p21 (Cdkn1a) in bone, suggesting mechanistic coupling between HIF-2α and cell
senescence. Furthermore, HIF-2α can bind to hypoxia response elements (HREs) in p16 and p21 promoters
and directly regulate their expression. While OCYs from aged mice express senescent markers, whether HIF-
2α controls OCY senescence is unknown. Our overall hypothesis is that HIF-2α expression increases with age
in OCYs and directly contributes to age-induced osteoporosis by promoting senescence-associated gene
expression. We will test this hypothesis by establishing the relationship between HIF-2α and senescent gene
signatures in OCYs during skeletal aging (Aim 1) and demonstrate that OCY HIF-2α stabilization drives a
senescent gene signature in OCYs using in vivo and in vitro approaches (Aim 2). Using micro-computed
tomography, biomechanics, and histology, we will demonstrate that Hif2a deletion prevents age-related bone
loss and preserves bone strength in mice (Aim 3). Our overall goal is to elucidate HIF-2α’s role in driving OCY
senescence and osteoporosis, revealing novel targets that can be harnessed pharmaceutically to prevent age-
induced senescent-related bone loss. This proposal describes a comprehensive research training plan,
supported by innovative facilities at UC Davis that will foster my scientific and professional development toward
my long-term goal of pursuing an academic research position.

Public health relevance
PROJECT NARRATIVE Age-related changes in bone occur via dysregulated skeletal remodeling, which predisposes bone to fracture and impairs both quality and longevity of life. Identifying the mechanisms by which mice acquire age-related osteoporosis can be used to identify novel therapeutic targets that subvert the associated decline in skeletal health.